Brainstem-forebrain networks and threat computation

Project Summary
A cardinal feature of anxiety disorders is exaggerated fear to cues signaling threat. The prevailing view of the
neural circuit for fear learning is a division of labor in which the amygdala and associated forebrain regions
signal threat probability, and brainstem regions organize fear output. This view is the intellectual foundation for
proposals that forebrain threat dysfunction drives exaggerated fear in anxiety disorders. Much more than
organizing fear output, my laboratory is showing brainstem networks compute prediction error – a learning
signal to drive fear learning. Further, brainstem networks signal threat – a function purported to be specific to
the forebrain. This proposal will reveal brainstem networks that signal threat probability, compute prediction
error, and organize fear output. Aim 1 will detail the emergence of brainstem threat and behavior signaling
dynamics. Female and male rats will receive Neuropixels implant through a complete dorsal-ventral brainstem
axis. Thousands of single units will be recorded from 20+ brainstem regions during a fear discrimination
procedure that produces selective learning to a threat cue. Firing analyses during the cue period will reveal the
emergence of brainstem network threat signaling and tracking of diverse behaviors over fear learning. Aim 2
will establish a framework for brainstem prediction error dynamics. Firing analyses during the outcome period
will link brainstem network firing dynamics for prediction error that precede the emergence of fear learning. Aim
3 will reveal forebrain inputs shaping brainstem firing dynamics and fear learning. Rats will receive brainstem
Neuropixels implant. AAV2-retro in a brainstem region and cre-casp3 in a forebrain region will be used to
delete specific inputs to the brainstem (e.g. prelimibic cortex neurons projecting to the periaqueductal gray).
Firing analyses comparing casp3 and control rats will reveal the dependence of brainstem firing dynamics
(threat, behavior, and prediction error) on forebrain inputs. Aim 4 will chemogenetically manipulate brainstem
firing to diminish prediction error computation and fear learning. Rats will receive brainstem Neuropixels
implant. Half will then receive excitatory DREADD infusions in regions flanking the periaqueductal gray –
sources of a tonic prediction error organized by firing inhibition. Actuator injections (JH60), but not saline
injection, will excite brainstem firing – blocking the tonic prediction error network. Firing analyses will reveal the
effects of network interruption on brainstem firing dynamics for threat, behavior, and prediction error. This
proposal will extend scientific knowledge by uncovering core threat functions of brainstem networks. The
proposal will further reveal how forebrain inputs shape brainstem firing dynamics that signal threat, compute
prediction error and organize specific fear behaviors. This knowledge is essential to developing effective
anxiety disorder treatments aimed to reduce fear.

Public health relevance
Project Narrative. There is an unmet clinical need for effective anxiety disorder treatments. The brainstem has been overlooked as a source of threat computation and a locus of dysfunction in disorders. This proposal will rigorously reveal threat signaling, prediction error computation, and specific fear behavior organization by brainstem networks: knowledge essential to developing effective anxiety disorder treatments.